Mechanistic Actions of PDZ Domain Mediated Protein Interactions on Neural Development and Anesthetic-Mediated Neurotoxicity

Project Summary:
In humans, multiple early exposures to procedures requiring anesthesia is a significant risk factor for
development of learning disabilities and disorders of attention and longer, but not shorter, durations of
anesthesia during a single exposure are also associated with adverse outcomes. While preclinical studies
show a dose–response relationship between the duration of general anesthesia and adverse cellular and
functional outcomes the underlying molecular mechanisms remain to be fully elucidated. Evidence indicates
that impaired hippocampal spinogenesis and synaptogenesis may be involved in the mechanisms by which
early anesthetic exposure produces long-term cognitive impairment, and that synaptic scaffolding protein PSD-
95 PDZ domain-mediated protein-protein interactions and synaptic activities are involved. Our previous studies
have demonstrated that PDZ domain-mediated protein interactions are disrupted by clinically relevant
concentrations of inhaled anesthetics. Recently, we showed that exposing postnatal day (PND) 7 mice to
isoflurane inhibits dendritic spine development, alters synaptic plasticity, and impairs learning and memory
function in relation to the anesthetic disruption of PSD-95 PDZ binding domains. Our results showed that the
disruption of PDZ interactions and PDZ domain-mediated synaptic function may play important roles in the
pathogenesis of early anesthetic exposure-produced long-term cognitive impairment. We hypothesize that
early exposure to inhalational anesthesia alters neural development by disrupting PDZ-domain mediated
interactions causing uncoupling of PSD-95-NMDAR and associated synaptic complexes resulting in inhibition
of several prominent downstream signaling pathways critical to dendritic spine, synapse, and arbor
development, thereby producing long-term neurocognitive dysfunction. To address this hypothesis, our aims
will identify the signaling pathways and mechanisms that link anesthesia induced uncoupling of PSD-95 PDZ-
NMDAR-nNOS synaptic complex to changes in spine and synapse maturation critical to neural circuit
formation (Aim 1); we will validate, in vivo, key downstream signaling components effected by disruption of the
synaptic complex, PSD-95-NMDAR-nNOS, and determine if restoring them can sufficiently prevent the
deleterious effects of anesthesia on dendritic spine and synaptic development, LTP, and memory (Aim 2);
assess whether PDZ domain disruption delays the NR2B to NR2A developmental switch, affects growing
dendrites and the spatial and temporal expression patterns of critical plasticity related proteins in glutamatergic
synapses, and determine if arbor disturbances can be prevented using over-expression and knock-down
approaches (Aim 3). The proposed studies will identify the signaling pathways and mechanisms linking
anesthesia induced uncoupling of PSD-95 PDZ-NMDAR and associated synaptic complexes to changes in
dendritic spine, synapse, and arbor development that lead to long-term cognitive impairment.

Public health relevance
Project Narrative: This project is focused on the investigation of PDZ-dependent synaptic scaffold protein interactions and corresponding downstream neuronal signaling during neurodevelopment and neurotoxicity in relationship to anesthetics. Our hypothesis is that early exposure to anesthesia alters neural development by disrupting PDZ- domain mediated interactions causing uncoupling of PSD-95-NMDAR associated synaptic complexes resulting in inhibition of several prominent downstream signaling pathways critical to dendritic spine, synapse, and arbor development. The overall goal of this project is to identify the signaling pathways and mechanisms that link anesthesia induced uncoupling of PSD-95 PDZ-NMDAR associated synaptic complexes to changes in dendritic spine, synapse, and arbor development underlying long-term cognitive impairment.